Study to Understand the Genetics of the Acute Response to Metformin & Glipizide

DESCRIPTION (provided by applicant): A growing number of common genetic variants have been robustly and reproducibly associated with type 2 diabetes (T2D). Despite these advances, the precise identity of the genes involved in increasing T2D risk has not yet been established. We propose to use pharmacogenetic and metabolomic approaches to inform the searches for causal variants and better define the molecular pathways involved. By challenging human subjects with a sulfonylurea or with glucose in the presence of metformin we hope to 1) distinguish responses depending on genotype at loci associated with T2D or related glycemic traits, or which impact metabolism of either drug; 2) confirm and expand an emerging metabolomic signature of insulin resistance by examining the human response to a glucose load with a larger panel of 380 metabolites (including lipid metabolites), 3) distinguish between the insulin and the glucose components of such response by discriminating the metabolomic profile in response to glucose versus the response to an insulin secretagogue; and 4) evaluate to what extent the refined metabolomic signature is correlated with genetic loci that predict insulin resistance. If successful, this proposal should help clarify the mechanisms by which genetic variants increase risk of T2D, and assess their impact on commonly used therapies. Whether the genetic defect is sufficient to prevent the expected action of either drug, or whether it can be overcome pharmacologically, would both be of clinical interest. In addition, this study should lay the groundwork for a longer outcomes-based pharmacogenetic trial.

Public health relevance
PUBLIC HEALTH RELEVANCE: Recent studies have identified a growing number of common genetic variants that are reproducibly associated with type 2 diabetes. Despite these advances, the precise identity of the genes involved in increasing diabetes risk has not yet been established, because in most cases the association signals detected merely signal genomic regions that are overrepresented in cases versus controls. We propose to use pharmacogenetic (describing the human response to a pharmacologic perturbation based on the genetic background of the individual) and metabolomic (describing the various metabolites that appear in serum in response to a perturbation) approaches to inform the searches for causal variants and better define the molecular pathways involved. NARRATIVE Recent studies have identified a growing number of common genetic variants that are reproducibly associated with type 2 diabetes. Despite these advances, the precise identity of the genes involved in increasing diabetes risk has not yet been established, because in most cases the association signals detected merely signal genomic regions that are overrepresented in cases versus controls. We propose to use pharmacogenetic (describing the human response to a pharmacologic perturbation based on the genetic background of the individual) and metabolomic (describing the various metabolites that appear in serum in response to a perturbation) approaches to inform the searches for causal variants and better define the molecular pathways involved. __SpecificAimsTextDelimiter__ 2. STATEMENT OF HYPOTHESIS AND SPECIFIC AIMS A growing number of common genetic variants have been robustly and reproducibly associated with type 2 diabetes (T2D) (1-3). Well-powered genetic association studies and, more recently, genome-wide association scans (GWAS) have identified almost two dozen loci where the statistical evidence of association with T2D has exceeded genome-wide significance, empirically established around 5 x 10-8 (4). Similar associations have been reported for related quantitative glycemic traits (5-11). Despite these advances, the precise identity of the genes involved in increasing T2D risk has not yet been established. In most cases, the association signals detected thus far merely signal genomic regions that are overrepresented in cases versus controls, and further fine-mapping and functional studies are necessary before a molecular mechanism can be ascribed to each locus in question. Fine-mapping often implies deep resequencing of the implicated DNA segments (coding and non-coding alike) and repeat tests of association in large samples (all at considerable expense), while functional cellular or animal studies require some knowledge about the exact genes or nucleotides that must be manipulated in in vitro systems. Nevertheless, progress in the translation of genetic discoveries to clinical practice can move forward along two parallel paths. On one hand, knowledge of the specific gene or variant causing the molecular phenotype is not needed to determine whether the associated region can aid prediction or affect the response to therapy; and on the other, complementary experimental approaches can be applied in vivo in humans that shed light on the function of genes that lie in the loci of interest, as a way to narrow the regions to study. Pharmacogenetics and metabolomics can fulfill both complementary roles. Through pharmacogenetics, the investigator can ask both whether particular genetic variants predict response to therapy, and whether a particular pharmacologic intervention impacts the mode of action of specific risk loci. Similarly, by assaying the metabolome before and after a pharmacological perturbation, the investigator can refine signatures that correspond to a particular metabolic state, a constellation of genetic risk factors, or a specific drug response, hoping to provide a molecular handle that might lead to the elucidation of genes and pathways. We therefore propose to examine the following Specific Aims: Specific Aim No.1: To examine the acute response to a sulfonylurea challenge (glipizide 5 mg orally) in subjects at risk of diabetes or with early diabetes (on diet treatment alone), depending on genotype at established loci associated with T2D or related glycemic traits, or which impact metabolism of the drug. 1. We hypothesize that subjects with variants that impair insulin secretion may have differential responses to sulfonylureas; whether the genetic defect is sufficient to prevent the expected action of the drug, or whether it can be overcome pharmacologically, would both be of clinical interest. Specific Aim No. 2: To examine the acute response to a glucose load in the presence of metformin (500 mg x 4) in subjects at risk of diabetes or with early diabetes (on diet treatment alone), depending on genotype at established loci associated with T2D or related glycemic traits, or which impact metabolism of the drug. 2. We hypothesize that subjects with variants that increase insulin resistance or alter metformin metabolism may experience differential responses to glucose in the presence of metformin; whether the genetic defect is sufficient to prevent the expected action of the drug, or whether it can be overcome pharmacologically, would both be of clinical interest. Specific Aim No. 3: To validate an emerging metabolomic signature of insulin resistance, to expand it by examining the human response to a glucose load with a larger panel of 380 metabolites (including lipid metabolites), to distinguish between the insulin and the glucose components of such response by discriminating the metabolomic profile in response to glucose versus the response to an insulin secretagogue, and to evaluate its correlation with genetic determinants of insulin resistance. 3. We hypothesize that an emerging metabolomic signature of insulin resistance will be further refined by the addition of more metabolites and by the distinction afforded by a glucose-mediated hyperglycemic insulin rise in comparison with a sulfonylurea-mediated hypoglycemic insulin rise. We further hypothesize that the refined signature will be correlated with insulin resistance variants. If successful, this proposal should help clarify the pathophysiologic mechanisms by which genetic variants increase risk of T2D, assess their impact on commonly used antidiabetic treatments, generate a unique resource, and lay the groundwork for a pharmacogenetic clinical trial.